Biomarkers of Dietary Intake and Exposure Data Coordinating Center

Project Summary/Abstract
The purpose of the Dietary Biomarker Development Centers (DBDCs) Consortium is to identify
biomarkers of dietary intake that can serve as independent markers of dietary intake and
complement current dietary intake assessment methods and the continually evolving evidence
base for addressing metabolic transformation of dietary constituents, especially the non-
nutrients by host and microbial metabolism. The Data Coordinating Center (DCC) aims to: 1)
provide a robust administrative management structure that enhances communication and
collaboration and improves the DBDC’s Consortium productivity and quality, 2) provide data
transfers, harmonization, integration, processing, and management, 3) develop a self-service
analytics platform and interactive reporting for users and conduct analyses, and 4) communicate
and disseminate knowledge within and beyond the Consortium. Operationally, the DCC will
develop manuals of operations, provide protocol training, establish and monitor timelines,
organize meetings with the Steering Committee (SC), NIDDK/USDA, and Data Safety and
Monitoring Board (DSMB). For data management, the DCC will establish a federally-compliant
online electronic data capture system to support the direct submission of data and a web-based
consortium communication and collaboration platform (CCCP) for secure data sharing and
dissemination of tools and results. The CCCP will have a link to access the self-service
analytics and interactive reporting to facilitate easy access to the data. The DCC will periodically
assess data quality, perform checks for data completeness, develop data documentation,
ensure protection of patient confidentiality, prepare reports for the SC and DSMB, and prepare
de-identified public use data files for submission into the NIDDK repository. Finally, the DCC will
provide thought leadership, biostatistical support, and methodological innovation to account for
the multi-faceted nature of dietary biomarker development, and facilitate the preparation and
dissemination of study results through multiple high-impact manuscripts and presentations. Our
team’s nationally recognized expertise in data management, harmonization, and coordination of
large networks, and our experience in biomarker research uniquely positions the DCRI to
provide all of the services and support required by the Consortium.

Public health relevance
Project Narrative The Data Coordinating Center (DCC) will enable the dietary biomarker development centers (DBDCs) Consortium to bring together multidisciplinary experts to enhance the field of dietary biomarker development by providing administrative, biostatistics, data management, self-service analytics, interactive reporting, and data analysis support to identify biomarkers of dietary intake. Specifically, the DCC will 1) provide a robust administrative management structure that enhances communication and improves the DBDC’s productivity and quality, 2) provide data harmonization, transfers, integration, processing, and management, 3) develop self-service analytics to generate data summaries, dynamic/interactive reporting, and analysis support for integrated biomarker validation, and 4) communicate and disseminate knowledge within and beyond the Consortium. Our team’s nationally recognized expertise in data management, harmonization, and coordination of large networks, and our experience in biomarker research uniquely positions the DCRI to provide all of the services and support required by the DBDC’s Consortium.